Communicating Waterpipe Tobacco Harms to Reduce Use among Young Adults

Project Summary
Young adults have the highest prevalence of waterpipe tobacco smoking (WTS) of any age group in the U.S.
Extensive evidence shows that they consistently misperceive WTS as less harmful and less addictive than
cigarette smoking, and these misperceptions are positively associated with WTS. Despite these widely held
misperceptions, WTS is associated with serious acute and chronic harms, even among infrequent users. In
addition, WTS is prospectively associated with cigarette smoking initiation putting young adults at greater risk
for cancer. Considerable evidence shows that cigarette warnings effectively convey health information to
consumers, resulting in increased motivation to quit and quit attempts. Waterpipe warnings have the potential
to convey accurate information about health harms to consumers, but the currently-mandated text warning,
focused solely on nicotine addiction, is likely to have limited impact. The goal of this project is to develop
warnings to promote greater understanding of harms and to reduce WTS behavior among young adults. We
will use a systematic, evidence-driven, rigorous approach to develop waterpipe warnings and test these newly-
developed warnings in two contexts: (1) on waterpipe tobacco packaging; and (2) in an ecologically-valid
waterpipe café setting. In Aim 1, we will develop text and pictorial waterpipe tobacco warnings to effectively
communicate a broad range of health harms. We will first develop 30 text warnings based on the most
robust science; then vet warnings with experts in WTS epidemiology, toxicity, and regulation. We will next
conduct a national survey to determine the five most effective text warnings, which will then each be paired
with three different images creating 15 pictorial warnings. We will conduct a second national survey to
determine the most promising image for each of the five text warning statements, resulting in five text and five
corresponding pictorial warnings to be carried forward to Aim 2. In Aim 2, we will evaluate the effect of text or
pictorial warnings on waterpipe tobacco packaging on WTS intentions using a nationally representative sample
of 1,500 young adults and will determine the two text and two corresponding pictorial warnings with the highest
perceived effectiveness for use in Aim 3. In Aim 3, we will determine the impact of text and pictorial warnings
displayed at waterpipe cafés on WTS behavior. We will conduct a three-arm (text, pictorial, no warning control)
cluster randomized crossover trial in 18 waterpipe cafés to determine the effect of warning type on young
adults' WTS behavior using an objective, biological marker of waterpipe tobacco consumption (expired carbon
monoxide). This study will contribute to a growing body of research on how best to design health warnings to
discourage WTS, and will identify important behavioral antecedents, which may include negative affect,
cognitive elaboration, perceived risks, and knowledge. The proposed research has the potential to make a
significant contribution towards cancer prevention by reducing WTS through the development and testing of
warnings that could influence local, state, and federal policies.

Public health relevance
Project Narrative Waterpipe tobacco smoking is common among young adults in the U.S. There are significant health effects associated with waterpipe tobacco smoking, but young adults erroneously believe it to be less harmful and addictive than cigarette smoking. This project will develop and test health warnings to increase young adults' accurate perceptions of harm and decrease use, which will lead to reductions in tobacco-related diseases, including cancers.